A Novel Fully-Polymeric, Biomimetic Prosthetic Mitral Valve Constructed from Clinically-Proven Materials to Improve Durability, Performance, and Overall Outcomes

PROJECT SUMMARY
Although biologic valve leaflets are the gold-standard for surgical mitral valve replacement, there are well-known
problems associated with valve durability, thrombosis, calcification, and immune response in surgical biologic
valves and transcatheter valves1. While mechanical valves are capable of lasting significantly longer when
compared with the biologic valve options, the significant drawback of anticoagulant requirements necessitate a
valve that combines the positive characteristics of both biologic and mechanical valves in order to improve patient
outcomes. PECA Labs has developed a novel mitral valve using a patented fluoropolymer formulation to create
bio-inert, highly antithrombogenic leaflets with flexibility and bio-compatibility of biologic surgical mitral valves,
the strength and resistance to wear of mechanical mitral valves, while being further bio-inert and anti-
thrombogenic when compared with both. PECA Labs has also developed a biomimetic shaping technique that
allows for the specialized polymer leaflets to feature improved hydrodynamic characteristics, including larger
EOA and reduced regurgitation. PECA Labs has shown success with polymer leaflets used in a pulmonary valve
that is currently in clinical trials within the US and has shown promising 6-month results.
Specific Aim 1 of this study is to subject the polymer leaflet material to hydrodynamic performance and durability
testing across multiple configurations to verify the material’s strength and movement properties. Hydrodynamic
and accelerated wear testing will be completed based on ISO 5840 guidelines for three sizes of the proposed
Mitral Valve. The valves will be subjected to 600 million cycles of accelerated wear testing with performance
evaluations using a pulse duplicator every 50 million cycles at hypotensive, normotensive and hypertensive
conditions to evaluate any wear and tear or hydrodynamic deficiencies. The valves will further be tested beyond
the 200 million cycle mark (a benchmark set within the ISO5840) until the valves are completely destroyed to
closely analyze the mechanisms of failure.
Specific Aim 2 of this study is feasibility testing to verify the in vivo functionality of the material. Mitral Valves
constructed with the novel polymeric, biomimetic material that is understood to be bio-inert and anti-
thrombogenic will be evaluated in a chronic large animal model to evaluate in vivo hydrodynamic characteristics
and allow for histopathologic evaluation of the valve for bio-inertness. This novel multi-layer fluoropolymer
formulation with biomimetic shaping is expected to have significantly lower valve-surface thrombosis and is
expected to further increase the longevity and functionality of the valve when compared to biologic leaflets. Thus,
this study will illustrate that the use of the novel leaflets provides equivalent or improved physiologic and
functional characteristics when compared with historical data on commercially-available biological valves in an
in vivo setting.

Public health relevance
PROJECT NARRATIVE Although biologic valve leaflets are the gold-standard of both surgical and transcatheter mitral valve replacement, there are well-known problems associated with valve durability, calcification, and immune response in surgical biologic valves, transcatheter valves, and pediatric valved conduits [1]. To avoid these issues and reduce the total number of interventions and surgeries, PECA Labs has developed a novel polymer valve leaflet material and a novel biomimetic leaflet shaping technique, which the proposed Phase I research project aims to validate through both extensive hydrodynamic and accelerated wear studies and a chronic in vivo study in a known pre- clinical model, building upon the success of the 14-day pilot large study already successfully completed, and the ongoing human clinical trial of a pulmonary valve that utilized the same novel polymeric leaflets. The proposed project represents the first steps towards making this polymer mitral valve commercially available, advancing the overall standard of replacement valves, reducing health care costs, and improving immediate and long-term surgical outcomes with an impact on all cardiac valve positions in the near future while also paving the pathway for future adaptation of the material technology used in the surgical mitral valve to transcatheter-mitral vavle.